Targeting MBNL1-mediated alternative splicing in MLL-fusion leukemia

Proposal Summary/Abstract:
Though outcomes for pediatric acute leukemia have improved dramatically over the last few decades, infant
leukemia is a particularly aggressive disease which remains difficult to cure even with chemotherapy
intensification and bone marrow transplant. Most of these leukemias carry a rearrangement of the MLL gene,
a phenomenon also seen in some de novo acute myeloid leukemias (AML) as well as therapy-related AML,
and studies have demonstrated that a common gene expression program underlies these leukemias
regardless of lineage. Through preliminary studies, we have found that MLL-fusion leukemias express high
levels of MBNL1, an RNA binding protein that regulates alternative RNA splicing. We have also identified an
alternative splicing (AS) signature unique to MLL-fusion leukemia, and show that MBNL1 loss causes reversion
of this signature and impairs MLL-fusion leukemia cell growth. We thus hypothesize that MBNL1 is a critical
regulator of an MLL-fusion specific AS program, and that disruption of this program via MBNL1 inhibition leads
to leukemia cell death. To test these hypotheses, our specific aims are 1) to determine the mechanism
underlying MLL-fusion leukemia dependence on MBNL1, and 2) optimize characteristics of a small-molecule
MBNL1 inhibitor as a treatment for MLL-fusion leukemia. To achieve the first aim, we will characterize changes
in key cell growth and death pathways which we hypothesize are responsible for the effects seen with genetic
knockdown. We will also identify novel MBNL1-mRNA interactions in MLL-fusion leukemia using CLIP-seq
(cross-linking immunoprecipitation with RNAseq). For the second aim, we have shown as a proof of concept
that a small molecule inhibitor of MBNL1 can induce MLL-fusion leukemia cell death. This compound requires
optimizations for potency, which we will achieve by applying medicinal chemistry principles. Furthermore, we
have used its structural characteristics and published crystal structures to initiate an in silico screen of a
proprietary compound library. This proposal will advance our understanding of the role of AS in the
pathogenesis of MLL-fusion leukemia, while also directly leading to a first-in-class therapy for this disease.
The applicant, who is currently an instructor in the Division of Oncology at Cincinnati Children’s Hospital
Medical Center, will execute this research plan while simultaneously engaging in structured didactics and
receiving close individual guidance from a panel of mentors as described in the application. These scientists
possess significant expertise in the molecular pathogenesis of leukemia. The experiments, mentoring, and
structured classwork described in this career development plan will position the applicant to successfully
transition into an independent researcher and physician-scientist, with expertise in the role of RNA binding
proteins in leukemia pathogenesis.

Public health relevance
Project Narrative: Leukemias with rearrangements of the MLL (KMT2A) gene, classically seen in infants and therapy-related leukemia, remain difficult to treat and cure even with modern therapies. These leukemias highly express an RNA binding protein, MBNL1, which regulates alternative RNA splicing and is essential for leukemia cell survival. The proposed research will explore the mechanisms underlying this dependence, and further develop a new and much-needed targeted therapy against this protein for this high-risk group of leukemias.